The Jackson Laboratory Senescence Tissue Mapping Center (JAX-Sen TMC)

PROJECT SUMMARY
This is a component of a collaborative project within the Cellular Senescence Network (SenNet) Program. We
have incorporated known senescence inducers (e.g. Doxorubicin, Palbociclib, high fat diet) in the mouse model
and shared relevant tissues (lung, muscle, ovary) with other SenNet TMCs for analysis. In the parent grant to
this supplement, we have established The Jackson Laboratory (JAX) Cellular Senescence Network Tissue
Mapping Center (JAX-Sen TMC) focused on the analysis of mouse tissue to address a significant research and
clinical need for improved biomarkers and cellular maps of senescence. Advances in our understanding of
biological aging and the recognition of aging as a modifiable risk factor for many chronic diseases and geriatric
syndromes are fueling a growing interest in the cellular underpinnings of the aging process. Despite recent
progress in cellular senescence research and the discovery of new senolytics and senomorphics, we lack clear
information regarding the role of cellular senescence in aging and age-related disease, and the effect of genetic
variation on these phenomena. In the JAX-Sen TMC we are mapping senescent cells in the context of multiple
age-matched tissues of genetically defined mouse cohorts, raised in standardized environments throughout their
lifespan and defining senescent cell phenotypes associated to features of genetics, age and senolytic
interventions. The tissues of specific focus within the JAX-Sen TMC are kidney, pancreas, heart, and placenta.
This supplement aims to generate detailed tissue mapping data on the mouse pancreas and kidney derived from
our senescence inducers study and perform the analysis of this data using our existing framework. Specifically,
we will employ bulk RNA-seq, H&E, CODEX multiplexed antibody imaging, and Xenium in situ RNA spatial
profiling. Senescent cells identified from the senescent inducers experiment will be directly compared to those
from natural aging, and provide the foundation for future senolytic/senomorphic functional studies.

Public health relevance
PROJECT NARRATIVE Senescence refers to the loss of cell function with aging and is associated with many chronic diseases of aging, but the mechanisms by which this happens is poorly understood at a molecular level. The proposed project seeks to advance knowledge of the molecular features of senescence through cutting-edge profiling techniques and mouse resources that will complement efforts at the human level to map senescence in human cells and tissues.